Role of ZBP1 in pathogenesis of Salmonella biofilms

PROJECT SUMMARY
Infections with enteric pathogens such as Salmonella, Campylobacter, Shigella, or Yersinia are leading causes
of morbidity and mortality worldwide. Although in most individuals the infection resolves, approximately 5% of
patients subsequently develop a painful chronic inflammatory condition known as Reactive Arthritis (ReA). How
Salmonella infections trigger ReA is not well understood. Using Salmonella enterica serovar Typhimurium (STm)
as a model organism, we discovered that a Salmonella protein, curli, is a dominant instigator of inflammation
following Salmonella infection. Curli is a secreted protein and major component of the STm biofilm in the
gastrointestinal tract. Curli fibrils bind extruded bacterial DNA within the biofilm. It is these curli:DNA complexes,
rather than curli alone, that are potent triggers of type I interferon, IL-17, and anti-double stranded DNA
autoantibody production, leading to ReA. Unknown, however, is why curli:DNA complexes are so inflammatory.
We report in this proposal the remarkable discovery that the DNA present within curli:DNA complexes is not
solely B-DNA, the classic right-handed (Watson-Crick) double-helix, but includes copious amounts of left-handed
Z-DNA as well. Z-form nucleic acids, such as Z-DNA and Z-RNA, were thought not to readily occur in nature,
until we showed last year that Z-RNA is indeed produced during virus infections and is a ligand for the
necroptosis-activating host sensor protein ZBP1. Our preliminary results now show that the Z-DNA within
curli:DNA complexes activates ZBP1 in intestinal epithelial cells (IECs) and fibroblasts, resulting in RIPK3-
dependent necroptosis of these cells. These findings allow us to put forward the hypothesis that Z-DNA within
curli:DNA fibrils in Salmonella biofilms activates ZBP1 to instigate RIPK3-dependent necroptosis in intestinal
epithelial cells (IECs) and other cell types. Necroptosis, in turn, causes cell loss and disrupts gut barrier integrity,
releasing inflammatory mediators that eventually result in autoimmunity and ReA. As necroptosis is a highly
inflammatory mode of cell death, these findings, at long last, supply a plausible mechanism for why curli:DNA
complexes are hyperinflammatory, and, therefore, for how Salmonella triggers ReA. They also identify Z-DNA
as a new PAMP, implicate ZBP1 – until now considered an antiviral protein – as a sensor of bacterial infections,
and position RIPK3 inhibitors as unanticipated new therapeutics for the treatment of ReA. In aim 1, we will
determine how Z-DNA forms within curli:DNA complexes, and how Z-DNA activates ZBP1. In aim 2, we will
identify the ZBP1-driven immune pathways that promote curli:DNA induced inflammation and ReA, and
determine the cell types in which ZBP1 signaling is important for pathogenesis. In aim 3, we will evaluate whether
necroptosis blockade with RIPK3 kinase inhibitors will have preventive or therapeutic benefit in ReA. A
successful outcome to these studies will outline an entirely new mechanism of Salmonella-triggered
inflammation. They also stand to open up exciting new therapeutic avenues for Salmonella-induced ReA, with
potentially game-changing ramifications for this currently incurable disease.

Public health relevance
PROJECT NARRATIVE Salmonella enterica infections of humans in the industrialized world are typically accompanied by acute gastro- intestinal symptoms; while most patients make full recoveries from such acute infections, a small, but significant, proportion of patients (~5%, or about 100,000 patients annually in the US alone) develop a debilitating chronic inflammatory disease called Reactive Arthritis (ReA). As ReA is currently incurable and has limited treatment options, understanding how Salmonella and other enteric infections result in ReA, and whether the pathways involved in this process are therapeutically targetable, each represent important unanswered questions. Here, we identify ZBP1-driven necroptosis as driver of Salmonella-triggered ReA, outline studies to understand how this pathway contributes to disease, and describe ways in which it can be exploited for therapeutic benefit in ReA.